IGF::OT::IGF OBTAIN CENSUS TRACT DATA 2010 TO 2020 BASED ON 2000 AND 2010 GEOGRAPHIES.

The primary functions of the Surveillance Research Program, DCCPS, NCI are to: (1) plan, develop, coordinate, and maintain a comprehensive national program to measure and report periodically on cancer in the United States population, providing accurate, reliable, and detailed national estimates of cancer incidence, survival and mortality, and integrates patient data with associated demographic, behavioral and medical data; (2) plan, develop and direct a quality control program which establishes, monitors and maintains national and international standards for collecting and reporting cancer statistics, and establishes national and international collaboration and liaison with organizations and agencies that promote comparability of cancer information systems; (3) plan and direct surveillance studies that coordinate with other research efforts in the Division, Institute, and other Federal agencies; and (4) develop and implement, using statistical modeling and operations research techniques, methodologies to resolve quantitative questions in cancer prevention, control, and surveillance, including analysis of trends, forecasting cancer rates, and development of models for diffusion of cancer control interventions